Postdoctoral Training Program for Research on Aging

PROJECT SUMMARY
The goals of the Robert and Arlene Kogod Center on Aging Training Program are to provide multidisciplinary
research opportunities for postdoctoral fellows at Mayo Clinic and to train them to be future leaders of
biomedical research in aging and age-related diseases. This is of critical importance in order to increase the
quality of life for the elderly as well as to reduce the societal and economic burden of chronic diseases and
frailty of age. Thus, this program aims to provide outstanding research and educational opportunities within the
setting of a state-of-the-art medical and research center. Twenty-one faculty members who are leaders in
basic, translational, and clinical research on various aspects of aging are available to mentor trainees. In
addition to the in depth scientific training that they will receive from their mentors, postdoctoral fellows (three
per year) will participate in workshops for grant writing and career development. Fellows will be expected to
submit applications for independent grants and to participate in a full array of programmatic activities, including
but not limited to journal clubs, seminars, national scientific meetings, and training in the responsible conduct
of research. This training program values individuals from diverse educational and societal backgrounds and
will benefit from the unique perspectives they bring to solving complex medical problems and reducing the
burden of age-related diseases on patients, their families, and our society.

Public health relevance
PROJECT NARRATIVE Chronic diseases account for the majority of morbidity and health care expenditures in the United States. Aging is the largest risk factor for most chronic diseases, including atherosclerosis, osteoporosis, many cancers, dementia, and diabetes. As people reach advanced age, they often face years of disability marked by chronic diseases, frailty, and loss of independence. Thus, the aim of this multidisciplinary Postdoctoral Training Program for Research on Aging is to provide focused training at Mayo Clinic to a new generation of researchers who will advance the science and treatment of aging and age-related diseases.